Role of Nuclear Pore-Regulated Mechanisms in Prostate Cancer Aggressiveness

PROJECT SUMMARY
Advanced carcinomas are among the most lethal human diseases, being metastatic prostate cancer (PC) a
classic example. Despite current treatments, metastatic PC progresses to a therapy resistant stage that
precedes lethality. Therefore, there is a need to identify new targetable mechanisms driving cancer
aggressiveness to continue improving patients’ outcome. The main objective of this research proposal is to
dissect the mechanisms by which Nuclear Pore Complexes (NPCs) regulate genome functions (gene expression
and integrity) in PC and uncover novel NPC-regulated targetable pathways using innovative pre-clinical models
of lethal PC. NPCs contribute to different biological functions through their building blocks nucleoporins (Nups),
including nucleo-cytoplasmic transport, chromatin organization, gene expression, genome integrity and mitotic
regulation. In the context of cancer, Nups have been associated to tumor formation and development, however
their specific mechanistic role in cancer pathogenesis remains largely unknown. Recently we identified clinically
relevant Nups upregulated in lethal PC through interrogation of publicly available patient tissue sample
transcriptomic datasets containing primary and castration-chemotherapy-resistant metastatic prostate tumors.
Within the upregulated Nups, POM121 was shown to play a role in the aggressiveness of lethal PC (cell survival,
proliferation and tumorigenesis) via nuclear transport regulation. Yet, the specific transport-dependent and -
independent mechanisms by which POM121 regulates the aggressive features of PC and its crosstalk with other
Nups remain unknown. Notably, functional genomic studies (transcriptomic and computational analysis)
combined with biochemical and single-cell high-resolution imaging have revealed a crosstalk between two top
upregulated Nups in lethal PC, POM121 and TPR, which impacts on the aggressiveness properties of PC cells.
Specifically, we found that PC cell survival is enhanced by the POM121 transcriptional regulation of specific
genome stability genes and TPR, which in turn regulates mitotic checkpoint activity, through Androgen Receptor
(AR)-dependent and independent mechanisms. Crucially, our studies have also uncovered a potential novel role
of soluble chromatin-bound Nups in the regulation of aggressive features of PC cells potentially through direct
transcriptional regulation. Thus, collectively these results led to the hypothesis that NPCs regulate PC
aggressiveness through multifaceted mechanisms controlling both genome functions and stability. We will
address this hypothesis and determine the Nup-specific mechanisms contributing to PC aggressiveness through
three aims. In Aim 1, we will define POM121 nuclear transport-dependent and -independent mechanisms
promoting PC aggressiveness. In Aim 2, we will examine the POM121-TPR mechanistic interplay enhancing
genome stability and cell survival in lethal PC. In Aim 3, we will evaluate the clinical significance and efficacy of
targeting specific NPC-regulated pathways controlling genome integrity in patient derived pre-clinical models.

Public health relevance
PROJECT NARRATIVE Tumor cells display nuclear pore and chromosomal defects, however, their specific mechanistic contribution to cancer progression is ill-defined. To enable the dissection of these intricate biological processes and their contribution to the aggressiveness of prostate cancer, our laboratory interrogates in vitro and in vivo patient- derived experimental models via transcriptomic, high-resolution live imaging microscopy, biochemistry and genetic approaches combined with publicly available patient datasets evaluation and patient tumor tissue validation. Our studies aim to identify novel actionable nuclear pore-regulated mechanisms in lethal prostate cancer that may benefit the clinical management of therapy refractory disease.